A quality and cost analysis of interprofessional team continuity in ICUs

PROJECT ABSTRACT
Critical care is the most complex, resource-intensive and costly care setting contributing over $130 billion to
national health expenditures annually. Approximately 4 million patients are admitted to intensive care units
(ICUs) each year with average mortality rate ranging from 8-19. Recently COVID-19 has highlighted that
staffing interprofessional teams in ICUs is quite challenging. One feature of healthcare staffing that has
received much attention in settings outside of the ICU is continuity of care – whereby a patient is cared for by a
small team of identified professionals over time – has been long recognized as an essential attribute of high-
quality, patient-centered care. In primary care, greater continuity of patient care is associated with fewer
emergency department visits and hospitalizations, lower healthcare costs, and higher patient satisfaction.
Continuity-based acute care staffing models also exist, but are rarely adopted and sustained in practice,
particularly in ICUs where continuity-based assignments can be challenging to operationalize. Importantly,
although critical care is delivered by interprofessional teams of physicians, nurses, and respiratory therapists,
continuity of interprofessional ICU teams has never been conceptualized or measured before. Without this
knowledge, it is difficult to know whether hospitals and administrators should prioritize continuity of ICU care,
which could be a missed opportunity to improve quality of patient care and outcomes in this critically ill, costly
patient population. The overall goal of our study is to examine the effect of continuity of ICU
interprofessional teams on patient outcomes and organizational economic outcomes, in order to
develop an interprofessional assignment decision-support tool that optimizes the continuity of
interprofessional ICU team care. We propose to examine the quality and costs of an interprofessional team
continuity staffing approach in ICUs to guide future interventions in 13 ICUs across two different healthcare
systems using data from over 2 years. We will examine interprofessional team continuity of shift-level ICU
clinician teams (a nurse, a physician, and a respiratory therapist) assigned to each patient during the ICU stay.
We define two dimensions of team continuity: intra-professional continuity, measuring each of the clinician’s
experience caring for the patient previously during the patient’s stay, and inter-professional continuity,
measuring the clinicians’ joint experience working together as a team. We hypothesize that care delivered by
shift-level ICU teams with higher intra- and inter-professional continuity will result in improved patient outcomes
and reduced costs. Our research team has a strong record of joint publications on attributes of patient care
teams including continuity of care with expertise in health economics, critical care nursing and medicine and
engineering. Completion of the study will generate the most robust evidence, to date, to inform organizational
priorities about continuity-based interprofessional staffing in ICUs, to improve care for critically ill ICU patients.

Public health relevance
PROJECT NARRATIVE This project will generate the most robust evidence to guide administrators about whether and how to prioritize continuity of care in ICUs to improve quality and minimize costs. We will use econometric methods (causal statistical methods), qualitative methods and optimization and simulation modeling to determine the quality and economic case for improving continuity of ICU interprofessional teams. The results will have direct impact on informing organizational approaches to human resource allocation in intensive care units in Michigan, Massachusetts and ultimately, nationally.